Humoral immunity after CAR-T cell therapy for B cell malignancies: The HICAR Study

PROJECT SUMMARY/ABSTRACT
The development of chimeric antigen receptor T cell therapies (CARTx) for B cell malignancies is a major
milestone in cancer immunotherapy with high rates of durable complete remissions. Although cytokine release
syndrome and neurotoxicity are the earliest and most dramatic immune related adverse events (irAEs) after
CARTx, severe manifestations are transient and only affect a minority of patients. In contrast, on-target, off-
tumor depletion of non-malignant B lineage cells affects the majority of patients and all long-term responders.
CD19 expression declines as B cells differentiate into plasma cells, whereas BCMA is selectively expressed by
plasma cells. Since plasma cells are responsible for maintaining long-lived antibodies and naïve/memory B cells
are important for generating new immunity, CD19 versus BCMA-CARTx may differentially affect preexisting
immunity and vaccine responses. Dr. Hill’s goal is to understand the long-term effects of CARTx on humoral
immunity. This proposal incorporates the expertise of an outstanding group of researchers in infectious diseases,
immuno-oncology, epidemiology, laboratory medicine, and statistics who are dedicated to ensuring the success
of this innovative research proposal. They will leverage their expertise and high-volume immunotherapy
programs to achieve the following aims.
The first Aim involves a prospective observational cohort study of 130 CARTx recipients (50 adult CD19, 50
pediatric CD19, 30 adult BCMA) with relapse-free survival ≥6 months. Dr. Hill will use a novel systematic viral
epitope scanning method (VirScan) to longitudinally characterize the antivirome to 206 viral pathogens. These
results will describe, and identify correlates of, antivirome diversity metrics at 6- and 12-months post-CARTx.
VirScan will allow for a nuanced assessment of the differential impacts of CARTx on humoral immune
competence. The second Aim will utilize samples from Aim 1 to determine the effect of CARTx on the durability
of preexisting humoral immunity to vaccine-preventable infections and the proportion of patients lacking
seroprotection after CARTx. These data will expand on Aim 1 to inform vaccination strategies. In the third Aim,
Dr. Hill will perform a prospective observational study of 95 CARTx recipients (50 adult CD19, 25 pediatric CD19,
and 20 adult BCMA) to define the frequency and correlates of positive vaccine responses ≥6 months after
CARTx. Patients will be vaccinated for S. pneumoniae, tetanus, diphtheria, pertussis, H. influenza b, and
hepatitis A and B according to institutional guidelines.
This proposal will address critical knowledge gaps by employing innovative methods to elucidate the scope of
pathogen-specific deficits in humoral immunity, and whether vaccination can mitigate these irAEs, after CARTx.
The findings will guide evidence-based strategies for infection prevention, such as vaccination or immunoglobulin
replacement, to improve outcomes in this rapidly growing population of high-risk individuals.

Public health relevance
PROJECT NARRATIVE The long-term effects of CAR-T cell therapies (CARTx) on pathogen-specific humoral immunity and infection risk are poorly understood. There are no data to guide evidence-based approaches to prophylactic strategies, such as vaccination or immunoglobulin replacement, to prevent infections in this rapidly growing high-risk population. This proposal will characterize antibody levels and vaccine responses after CARTx, and how these results vary by treatment and clinical characteristics, to improve long-term outcomes after CARTx.